Adaption, Implementation and Testing of a Telehealth Diabetes Discharge Intervention to Improve Transitions of Care

Abstract/Project Summary: High-risk medication use is essential for certain disease states, such as diabetes
mellitus, and transitions of care can be an especially hazardous time for those new to diabetes medications.
Novel delivery methods, especially for telehealth, are needed in for the peri- and post-COVID era. The sickest
population of patients, those with diabetes in the hospital, often require in depth knowledge and education
transfer, as they transition from the inpatient to outpatient setting, but currently are getting in person and/or
telemedicine training. The goal of this research project is to adapt a diabetes discharge toolkit [integrated
software (website/app/print) and hardware (3-D printed kit) system] for use in a telehealth setting, utilizing
novel learning science methods. We then propose to integrate and implement an intervention testing the newly
adapted Telehealth Diabetes Discharge Toolkit for those requiring new and/or additional DM medications, and
additional diabetes education at discharge. The goal will be to evaluate the implementation of the DM Toolkit at
discharge, and then assess the feasibility of a pilot clinical trial of the intervention on glycemic control and
glycemic excursions as well as other self-care and psychosocial measures.

Public health relevance
Project Narrative: There is a clear need for improvement in the diabetes mellitus (DM) transitions of care from the hospital to home. This research focuses on adapting, integrating, implementing, and testing, through a clinical trial, a telehealth diabetes discharge toolkit designed to improve glucose control, safety, and diabetes self-care, and psychosocial measures following discharge from the hospital for those new to DM medications and requiring additional diabetes education. This intervention has the potential to be generalized to DM care in other care settings (e.g., emergency department, outpatient clinic) for DM patients.